Protein/Structure Core

PROJECT SUMMARY: PROTEIN CORE The Protein Core provides the technology, infrastructure and expertise required for the high-throughput production of protein reagents to support the Ligand Discovery, Structure Determination and Functional Annotation goals of the Program Project. The Protein Core will generate ~450 proteins per annum (native and seleno-methionine substituted, as needed) for function and structure. Initial efforts will focus on the production of Solute Binding Proteins (SBPs) and Ligand-responsive Transcriptional Regulators. Efforts will also include “pathway-related” enzymes, as required for confirmation of metabolic pathway prediction by the Metabolism and Modeling Projects. The Protein Core will exploit its great flexibility to respond to the changing needs of the Program Project by providing access to the widest range of required proteins. This includes the generation of oxygen sensitive proteins involved in amino acid and carbohydrate metabolism by exploiting the world's first integrated system for high-throughput functional and structural biology of oxygen sensitive proteins, a recapitulation of our entire high-throughput protein production and crystallization pipeline within an oxygen-free environment. In summary, we established a world class protein production resource which has supported the high- throughput structural, DSF, activity-based screening and functional assay requirements for a number of large- scale research programs and which will continue to do so for this Program Project.